Vanderbilt Alzheimer's Disease Research Center: DMS Core

PROJECT SUMMARY – DATA MANAGEMENT AND STATISTICAL CORE
The Vanderbilt Alzheimer’s Disease Research Center (VADRC) Data Management and Statistical (DMS) Core
will provide data coordination and statistical expertise to support our mission of characterizing the intersection
of vascular burden with Alzheimer’s disease (AD) and related dementias (ADRD) at the cellular, systems
biological, and population levels. The DMS Core will interact with all VADRC Cores and the Research
Education Component (REC), enhance existing informatics infrastructure, and develop new infrastructure as
needed to support local research and contribute to collaborative national and international research initiatives.
The DMS Core will provide consolidated data capture solutions by maintaining and expanding Center-wide
relational databases for VADRC participant recruitment, screening, referral, and data capture needs. We will
also coordinate high quality data management to support needs across all VADRC Cores, including data
cleaning, data querying, and database quality control. The DMS Core has established a centralized and
versatile informatics infrastructure to facilitate VADRC data and resource sharing. This infrastructure supports
timely submission of all appropriate data to the National Alzheimer’s Coordinating Center and the Laboratory of
Neuro Imaging. It also includes our data sharing portal where investigators can request data, images,
biospecimens, and participant referrals; utilization of Flight Tracker to track REC outcomes and milestones;
and management of our Participant Information Tracking and Coordination Hub. In collaboration with the
Outreach, Recruitment, and Engagement Core, this latter tool tracks outreach events, referrals, participant
recruitment requests, and participant study status, and features internal reports and dashboards to evaluate
recruitment strategies and referral success. The DMS Core will develop novel applications as needed to assist
REC scholars and affiliated VADRC investigators with statistical and analytical needs. Core services will
include, among others, (a) study design and power considerations, (b) statistical analysis of VADRC data with
an emphasis on advanced multivariate longitudinal models, and (c) interpretation of statistical results. Finally,
the DMS Core will develop and apply innovative statistical and informatics methods for data harmonization and
multivariate longitudinal modeling aimed at better characterizing vascular contributions to ADRD.